Visualizing insulin actions on neuronal metabolism and function using fluorescent biosensors

Insulin resistance produces a failure of peripheral tissues (e.g. muscle and liver) and the brain to
appropriately utilize glucose and generate ATP. The prevalence of this condition in aging individuals, as well
as in several pathologies associated with cognitive decline, represents a major challenge for the health care
system. Importantly, the brain requires ~20% of the total energy output of the body but contains only limited
energy reserves. As a result, the brain is highly vulnerable to hypoglycemia and hypometabolic states that
occur in neurological disorders. However, the role of insulin on the complex regulation of energy metabolism
and homeostasis in neurons remains unknown. Patients with prediabetes or T2DM13 exhibit both insulin
resistance and cognitive impairment. However, despite several studies suggesting an association between
brain insulin resistance and cognitive decline, the role of insulin signaling on brain energy homeostasis and
cognitive performance remains an enigma. Mechanistic studies on the neuronal actions of insulin have been
limited to cultured cells that ignore the complex interactions between neurons and astrocytes that are critical
to energy homeostasis. The premise of this application is based on the fact that an integrated view of insulin
action on energy metabolism is not available but is required to understand and develop interventions for the
effects of diabetes and multiple other diseases that impact cognitive health. The project proposed here is
specially focused on advancing our basic understanding of insulin regulation of neuronal energy metabolism,
and its consequences for neuronal excitability, neurotransmission, and behavior. We will detect simultaneous
readouts of neuronal excitability and metabolism in brain slices, a model that preserves the complex 3D
organization and circuitry of native brain tissue. We hypothesize that glycolysis and oxidative phosphorylation
in neurons are directly regulated by insulin signaling, which result in an increase in energy metabolism,
calcium clearance, neurotransmission, and synaptic plasticity. The following aims are proposed: Aim 1:
Define the mechanisms of insulin signaling on energy metabolism in neurons. Aim 2: Characterize the role
of neuronal insulin signaling on cytosolic calcium dynamics and synaptic plasticity in the hippocampus. Aim
3: Investigate the role of neuronal insulin resistance on learning and memory. The proposed studies will form
the foundation and preliminary data necessary for an R01 application to NIH focused on insulin effects on
neuronal metabolism in health and disease.

Public health relevance
Insulin actions on fuel utilization in cells have been extensively studied in muscle, liver and fat, but not as much in the brain. Here, we will explore how disrupting several steps of the insulin signaling cascade may impact glucose consumption in neurons, and how this affects neuronal function at the cellular level. Ultimately, the implications of impairing insulin actions will be assessed in behavioral tests to determine whether the effects of insulin on neurons have an important role in learning and memory.